Cedars Sinai Clinical Center of the Type 1 Diabetes in Acute Pancreatitis Consortium

This is an application for renewal of Clinical Center designation from the Cedars-Sinai Center for the Type 1
Diabetes in Acute Pancreatitis Consortium (T1DAPC). The Cedars-Sinai Clinical Center has provided
considerable leadership in the progress of the main cohort study of the T1DAPC, called the Diabetes Related to
Acute Pancreatitis and its Mechanisms (DREAM) study. Dr. Pandol co-chairs the Ancillary and Associated
Studies Committee while Dr. Goodarzi chairs the Genetics Interest Group, leading the Consortium’s initiatives
to define the genetic risk of diabetes occurring after acute pancreatitis. We have successfully addressed
challenges in recruitment and retention of subjects in the cohort studies to significantly improve our performance,
as described in this application. Moreover, we have proposed and obtained approval for two key ancillary studies
(described in Aims 2 and 3). For the next phase of the Consortium, we are committed to the following Specific
Aims:
Specific Aim 1. Continue recruitment and retention of participants in the DREAM study.
We will describe our progress in recruitment to date and how we have addressed challenges to improve
recruitment and retention.
Specific Aim 2. Identify biomarkers and pathways of progression of acute pancreatitis to recurrent acute
and chronic pancreatitis.
Identification of patients with a high probability of progressing pancreatic disease and molecular pathways
mediating progression is a major goal for the field. This project is designed to use a mass spectroscopy
proteomics-based model for prediction of progression as well as identify molecular targets that can be developed
into therapeutics for prevention of progression after an acute episode of pancreatitis.
Specific Aim 3. Evaluate genetic risk factors for diabetes in patients with AP or RAP.
Large-scale genome-wide association study (GWAS) meta-analyses have identified many non-overlapping
SNPs that predispose to T1DM or T2DM. These SNPs will be genotyped in DREAM participants with AP or RAP
who do not have diabetes at enrollment. We will determine whether genetic risk is a major contributor to the
future development of diabetes. Given that genetic risk scores based on GWAS SNPs can distinguish between
different types of diabetes, we anticipate that the genetic profile will be able not only to improve diabetes
prediction but also allow the type of diabetes (T1DM vs T2DM) to be predicted.
We will carry out the aims with a leading interdisciplinary team committed to collaborative research with other
Centers and the Data Coordinating Center (DCC) of the Consortium to continue to address and resolve the
outstanding gaps in the field.

Public health relevance
This is an application from the Cedars-Sinai Center for the Type 1 Diabetes in Acute Pancreatitis Consortium. The Cedars-Sinai Center will contribute to the overall goals of the Consortium to (a) determine the cumulative incidence and clinical characteristics associated with the development of diabetes after one or more episodes of acute pancreatitis; (b) comprehensively characterize beta-cell function and endocrine alterations after acute pancreatitis and their relationship with the development of diabetes after acute pancreatitis; and (c) determine the immunologic mechanisms of diabetes after acute pancreatitis, including the contribution of beta-cell autoimmunity.